Applying Service Design Methods to Enhance Implementation and Adoption of a Digital Graded Exposure Treatment for Youth with Chronic Musculoskeletal Pain in Clinical Settings

Abstract
Chronic musculoskeletal (MSK) pain affects the lives of over a quarter of youth and impacts multiple domains of
functioning, including social, emotional, and behavioral functioning. Digital behavioral health interventions offer
solutions to existing access to care barriers, with outcomes similar to in-vivo treatment. Despite this, only 28%
of digital tools are disseminated adequately or timely. Most research on digital interventions has focused on
evaluating efficacy and adoption in the context of clinical trials but have largely ignored service design, the
process in which patients and clinicians engage with each other and with technologies when integrating an
intervention into practice. Ignoring the users or contexts (e.g., clinics) in which interventions are implemented
leads to suboptimal healthcare innovation and significant research waste. Given this, there is an imperative need
to integrate service design methods as part of the development of digital behavioral interventions for youth with
chronic MSK pain. With my K23 Mentored Patient-Oriented Research Career Development award, I am
designing and evaluating feasibility and preliminary efficacy of iGET Living, a digital graded exposure treatment
(GET) for youth with chronic MSK pain. My long-term goal for this program of research is to establish iGET Living
as an evidence-based intervention that is scalable and sustainable and can be broadly implemented in clinical
care. To achieve this goal, I need to design the intervention (K23), understand how to integrate it into clinical
care (R03), and validate its effectiveness and implementation in a hybrid trial (R01). The overall objective of this
R03 small grant program application is to apply service design methods to understand how to implement iGET
Living in three clinical settings. I will partner with three clinics that are typical settings youth with chronic MSK
present and are the planned sites of a subsequent R01: pain management, rheumatology, and
orthopedics/sports medicine. Using the 4-Phase Double Diamond Model design process, I will apply service
design methodologies and collaborate with the clinics to create two products that describe how iGET Living will
be embedded in each setting: Service blueprints and implementation roadmaps. Service blueprints are diagrams
of the touchpoints when person-to-person and person-to-technology transactions occur through the intervention
delivery process. Implementation roadmaps specify the implementation strategies and adaptions to the
intervention and settings that are needed to support implementing the service blueprints for iGET Living.
Dedicated attention to service design in advance of an R01 investigation is ideal for: 1) strengthening
partnerships with the clinics for longer-term collaboration; 2) accelerating the timeline to deliver the intervention
to patients by completing the implementation-preparation activities; and 3) identifying ways to address potential
challenges when conducting research in real-world settings so they can be later avoided. Designing for the
delivery of iGET Living for pediatric MSK pain will accelerate my science from K23 to R01 effectiveness-
implementation investigation and propel digital intervention research toward improved engagement and impact.

Public health relevance
Project Narrative Digital health represents a seismic shift in medicine that is revolutionizing how patients receive clinical care and engage with providers, but integrating new interventions into existing clinical workflows is challenging--- highlighting the need to consider how digital interventions are implemented in clinical settings and design them to fit into the existing workflows of the settings in which they will be used. The proposed study aims to utilize service design methodologies to evaluate the workflows of three clinical settings where youth with chronic musculoskeletal pain present for care and develop service design products to support successful implementation of a digital graded exposure treatment for youth into clinical practice. Dedicated attention to service design in the development of the digital intervention will ensure the intervention is aligned with its implementation context, maximizing adoption and clinical impact.